Systems analysis and improvement to optimize opioid use disorder care quality and continuity for patients exiting jail (SAIA-MOUD).

Opioid-related overdose deaths in the United States are skyrocketing, including in Washington State (WA) where
overdose deaths rose 37% from 2021-2022. Estimates suggest that over 50% of people with opioid use disorder
(OUD) pass through WA jails each year. Jail incarceration causes a dramatic increase in overdose risk following
release, in addition to compounding marginalization that hinders management of OUD. Treatment with evidence-
based Medications for Opioid Use Disorder (MOUD) effectively manages OUD, reduces patients’ overdose risk,
and reduces rates of recidivism. WA has prioritized improving access to MOUD, including for individuals
incarcerated in jails, however systemic weaknesses exist in the handoff of care from jail to clinical referral sites
and there is little focus on developing strategies that foster linkages between services. Low-cost, systems-level
interventions are effective and efficient approaches to improve linked cascade services and may improve
linkages between jails and referral clinical services, improve flow through the MOUD cascade, address barriers
to holistic OUD care, and ultimately reduce unmanaged OUD, recidivism, and mortality. The Systems Analysis
and Improvement Approach (SAIA) is an evidence-based implementation strategy of bundled systems
engineering tools designed to optimize complex healthcare delivery systems and improve linkages between
clinical and community providers. The SAIA-MOUD study aims to strengthen the quality and continuity of MOUD
care, and linkages to social services, across jail and referral clinics in King County, WA. We will implement the
SAIA for three years—including a two-year intensive phase and one year of sustainment—at one jail based
MOUD program and two referral MOUD clinics. We will then evaluate the effectiveness of SAIA on improving
MOUD cascade quality and continuity for patients receiving care in jail and exiting to referral clinics, determining
the effect on linkage to care within 14 days of release. A secondary outcome of retention (those who return for
a second MOUD pick up within a month of initial linkage) will be considered. We will describe—and explore
determinants of—adoption, implementation, and sustainment of SAIA-MOUD via qualitative inquiry with jail and
clinic staff. Analysis will be guided by the Consolidated Framework for Implementation Research (CFIR) and the
Framework for Reporting Adaptations and Modification to Evidence-based Implementation Strategies (FRAME-
IS) will be used to document implementation strategy adaptations. We will estimate the cost and cost-
effectiveness of SAIA-MOUD using the cost per additional client linked to MOUD referral clinics upon release
from jail as well as quality-adjusted life year gained from the county government, healthcare sector, and societal
perspectives. Using a micro-costing approach, we will estimate the incremental costs per additional patient
passing through the MOUD cascade. The results of this implementation research are expected to develop the
evidence base on how a systems-focused intervention applied to a novel clinical cascade can lead to measurable
improvements in cascade functioning and patient-level outcomes for a significant, national public health threat.

Public health relevance
PROJECT NARRATIVE Optimizing the Medications for Opioid Use Disorder (MOUD) cascade across the continuum of care between jail and clinical referral sites may minimize drop offs and maximize the benefits of MOUD on managing OUD, reducing overdose risk, and reducing rates of recidivism. This proposal evaluates the effectiveness of a health systems intervention (the Systems Analysis and Improvement Approach - SAIA) that packages systems engineering tools (including cascade analysis, flow mapping, and continuous quality improvement) to optimize the MOUD cascade and improve linkages between jails and clinical referral sites. By 1) studying the effectiveness of SAIA on MOUD care cascade quality and continuity for patients receiving care in jail and exiting to referral clinics, 2) exploring determinants of adoption, implementation, and sustainment of SAIA-MOUD, and 3) estimating the cost and cost-effectiveness of SAIA-MOUD, this study will build evidence on how to achieve rapid, sustainable and scalable improvements in services that can dramatically improve cascade functioning and patient-level outcomes for a significant, national public health threat.